The Nexus of Trained Immunity and Stable Immune Complexes: Implications for Aging-Related Conditions in PLWH

Project summary
Approximately 38.4 million people are living with HIV globally, and there are still new infections daily. People
living with HIV on antiretroviral therapy are aging at a faster rate than their peers. This is likely driven by the
HIV reservoir that persists even in aviremic patients. The HIV reservoir and other co-infections, such as
cytomegalovirus (CMV), promote chronic inflammation, which further contributes to accelerated aging. Our
overarching hypothesis is that chronic inflammation accelerates aging-related diseases such as diabetes,
cardiovascular disease, and cancer in people living with HIV, even in the absence of detectable viral load. In
previous studies, our group demonstrated that people living with HIV exhibit a significant increase in CMV-
specific CD4+ T cells, a phenomenon described as 'inflation.' This inflation is unique to HIV, as similar
increases have not been observed in studies of immune suppression in transplant patients, suggesting an
interaction between HIV and CMV. Beyond this, people living with HIV with metabolic disease have increased
proportions of circulating immune complexes (CD3+ T cell CD14+ monocytes). Traditionally, these complexes
have been dismissed as artifacts. However, studies suggest that these are functional complexes. In people
with HIV, these complexes are activated, inversely correlated with CD4+ regulatory T cells and plasma
interleukin (IL)-10 levels and contain replicating HIV. These findings highlight the role of these complexes in
HIV and metabolic diseases. Given their functional nature, CD3+ T cell CD14+ monocyte complexes provide a
unique opportunity to define the antigen drivers in diabetes, cardiovascular disease, and aging to develop
targeted immune interventions with fewer adverse effects. This proposal will leverage the Center for AIDS
Research Network of Integrated Clinical Systems (CNICS), a longitudinal cohort of patients with adjudicated
outcomes across multiple sites, to study the immune complexes over time. We propose three aims. In the first
aim, we will investigate whether immune complexes are elevated in people living with HIV who also have
cardiovascular disease or cancer. This approach will enable us to determine whether the immune complexes in
these individuals differ functionally from those found in people living with HIV and diabetes. In the second aim,
we will test the hypothesis that both host-derived factors, such as major histocompatibility complexes, and non-
host-derived factors, including smoking, metabolites, and lipids, promote the formation and persistence of
immune complexes. Finally, the third aim will examine whether CD3+ T cells within these complexes induce
epigenetic changes in CD14+ monocytes, leading to pathogenic trained immunity. We seek to identify
mechanisms driving aging in people living with HIV, ultimately paving the way for targeted therapies that could
slow down aging and reduce comorbidities in this population. Our findings will inform the development of
targeted anti-inflammatory therapies, potentially transforming the management of aging-related comorbidities.

Public health relevance
Narrative People living with HIV and diabetes who are on antiretroviral therapy have an increased number of circulating immune complexes compared to those with HIV but without diabetes. These immune complexes are more inflammatory and likely to contribute to systemic inflammation and other diseases of aging. The complexes likely represent a snapshot of interactions where cells within the complexes influence each other and may offer insight into the mechanisms of persistent chronic inflammation.